Prevention of Injuries Among Young Children: Tailoring a Home Supervision Intervention for Latinx Caregivers

Summary
The proposed study will modify and test an intervention to reduce unintentional
injuries among Latinx children by teaching their caregivers to supervise their young
children (ages 2-5 years) more effectively. The study will include 5 steps. In step 1, we
will conduct focus groups with Latinx families and staff from Latinx resource centers to
identify modifications that need to be made to the intervention materials. In step 2, we
will make modifications to the intervention materials based on focus group feedback. In
step 3, we will conduct a second round of focus groups with Latinx caregivers and staff
from Latinx resource centers to determine if additional modifications need to be made to
the intervention. In step 4, we will pilot test the modified intervention with Latinx
families and will make final modifications to the intervention. Finally, in step 5, we will
test the effects of the modified intervention on caregivers’ supervision and children’s
injury frequency among Latinx families. We will recruit participants from Latinx
resources centers in three communities in Southwest Michigan. We will also recruit
families from a local Head Start program. We will use a randomized controlled trial
methodology to examine the efficacy of the intervention to increase caregiver supervision
and reduce and child injuries. Self-report and observational data on supervision will be
collected at pretest, post-test and at a 1-month follow-up. Data on child injuries will be
collected at pre-test (for the previous 2 week period), during the 3 week intervention,
and during a 4-week follow-up via brief weekly telephone interviews with caregivers.

Public health relevance
Project Narrative Unintentional injuries are the leading cause of children in the United States. The project will modify an intervention designed to increase caregiver supervision of young children for use with Latinx families. The study will test the modified program with Latinx families of children ages 2-5 years.